ONCOGENE EXPRESSION IN CELL LINES DERIVED FROM HUMAN HEPATOCELLULAR CARCINOMA

The possible role of oncogenes in the development of human hepatocellular carcinoma (HCC) has not been well defined. We have examined several cell lines from human HCC, as well as a control (non-HCC) cell line (WI-38) for levels of expression of oncogenes. The expression of thirteen oncogenes (c-myc, H-ras, K-ras, N-ras, raf, Mb, abl, N-myc, erb-A, erb-B, fos, src, and mos) and two tumor suppressor genes (Rb and p53) were studied by northern blot hybridization in three human HCC/HB cell lines (PLC/PRF/5, Hep3B, and Hep G2) and in a human embryonic lung fibroblast cell line (WI-38) to look for differences that might be associated with the presence (PLC/PRF/5 and Hep3B) or absence (Hep G2) of integrated hepatitis B virus (HBV) DNA. Most of the oncogenes were expressed at a higher level (based on band intensity) in HCC/HB cell lines than in WI-38 cell lines (exceptions: K-ras, fos, and Rb were expressed at the same level in all four cell lines; p53 was not detectable in Hep3B). Certain oncogenes (c-myc, H-ras, raf, src) were expressed at different levels among the three HCC/HB cell lines, unrelated to the presence or absence of integrated HBV-DNA. Additional studies were conducted using additional human HCC cell lines: 2.2.15 (which is derived from Hep G2 transfected with HBV) and the three Japanese lines: HLE, HLF, and HuH7. The data for these lines are still being analyzed.